Mapping Molecular Pathways that Control Prion Metabolism

Project summary
Mammalian prion diseases, such as Creutzfeldt-Jakob disease (CJD), Chronic Wasting Disease
(CWD), bovine spongiform encephalopathy (BSE), and scrapie, are a group of infectious
neurodegenerative disorders caused by the autocatalytic conversion of the host-encoded prion
protein, PrPC, into a group of misfolded, infectious conformers collectively termed PrPSc.
Multiple lines of evidence from biochemical, genetic, and cell biological studies suggest that
PrPC and PrPSc employ specific pathways for biosynthesis, trafficking, and degradation in living
cells. However, full elucidation of these pathways has been hindered the lack of tractable model
organisms for genetic screening. To overcome this obstacle, we recently developed methods to
detect both PrPC and PrPSc in brain-derived CAD5 cells using fluorescence-activated cell sorting
(FACS). We will use these sensitive sorting methods to perform CRISPR (clustered regularly
interspaced short palindromic repeats)/Cas9 whole genome library screens in CAD5 cells
infected with different prion strains. These studies will be the first to fully map the molecular
pathways that control the biosynthesis, trafficking, and degradation of both PrPC and PrPSc
molecules, and thereby greatly advance our fundamental knowledge of prion cell biology. Our
unbiased screens will also reveal the rate limiting steps of prion formation and clearance,
thereby identifying the most susceptible targets for drug therapy.

Public health relevance
Project narrative Creutzfeldt-Jakob disease (CJD), Chronic Wasting Disease (CWD), bovine spongiform encephalopathy (BSE), and scrapie, are a group of infectious fatal brain diseases caused misfolded proteins known as prions. We propose to use a powerful new approach that leverages the power of next generation sequencing to identify all of the genes that regulate prion metabolism in cells. These studies will provide for the first time a complete and unbiased map of the molecular pathways used by living cells to make and destroy prions, and thereby advance our fundamental knowledge of prion cell biology and identify novel targets for drug therapy.